Global Cardiometabolic Disease Training

Abstract
We propose to renew our global cardiometabolic disease (GCMD) predoctoral training program. This cross-
disciplinary nutrition-focused program provides specialized training to develop a cadre of researchers who
can bridge basic, translational, and population science to reduce the growing burden and disparities in
GCMD. There is critical need to reduce this burden in low- and middle-income countries that are
disproportionately affected and where more specialized skills and global leadership are most needed. The
training program is administered in the Department of Nutrition in the Gillings School of Global Public Health
and in the UNC School of Medicine, a logical and well-placed home for a GCMD training grant. Nutrition
science integrates “omics” (e.g., genomics, proteomics, metabolomics), behavioral, and population
approaches and data to understand complex pathobiological processes and underlying causes of population
health differences in GCMD, thus providing a strong platform for training translational global researchers in
this field. Our program is co-directed by two senior faculty with strong mentoring records and extensive
global experience and leadership in GCMD research. The program is guided by an internal training
committee and an external advisory board. Our 22 UNC training faculty are scientists with substantial
research support, excellent publication records across a wide range of disciplines, and strong mentoring
experience. We request support for 5 predoctoral trainees per year. Trainees complete the PhD in nutrition
and GCMD program-specific requirements, including specialized courses in global health and
cardiovascular disease and options for in-depth training in (1) specialized methods important for GCMD, (2)
translational medicine, or (3) implementation science. All trainees participate in a seminar led by the program
directors, mentored research practicums, training in the responsible conduct of research, and mentoring for
professional development, including submitting an NIH-style predoctoral and/or F award or similar
application for extramural funding, and unique global internships with 15 global mentors who are exceptional
CMD researchers working at 13 top universities or research centers in 11 countries. Our training program
stands out because of its: (1) focus on nutrition, a major etiologic factor in the global disease burden; (2) life
course approach to addressing GCMD; (3) interdisciplinary focus on causes ranging from cellular and
molecular to whole organism and accounting for underlying social, economic, political, and environmental
determinants; (4) emphasis on integration and translation of basic knowledge and discoveries from nutrition
biochemistry, physiology, genetics, and epidemiology, to behavioral and environmental approaches and
policies; and (5) outstanding faculty mentors who serve as role models for excellence in GCMD research
and leaders working with countries to implement and evaluate large-scale regulatory efforts to prevent
cardiometabolic disease. The program is training future leaders in GCMD research.

Public health relevance
Project Narrative Cardiometabolic diseases currently pose one of the biggest threats to health and development globally, particularly in low- and middle-income countries. Despite calls from expert panels, little progress has been made in reducing this disease burden. We propose a nutrition-focused interdisciplinary predoctoral program to train leaders with expertise across global cardiometabolic disease biology, epidemiology, social, and environmental determinants that will translate to effective individual and global policy prevention strategies.